Development of phosphorylation editing chimeras using kinase inhibitors

PROJECT SUMMARY
Protein post-translational modifications (PTMs) can activate, inhibit, or modify protein’s function. Small molecules
that inhibit enzymes that induce PTMs (e.g., kinases for phosphorylation) are available in abundance, but
methods to induce a given PTM of any protein on demand are challenging to develop. We propose to develop a
new class of small molecules which will induce protein phosphorylation by using a kinase inhibitor to recruit the
given kinase to phosphorylate a neo-substrate. These molecules will be formed by joining a small-molecule
kinase inhibitor with a small-molecule binder of the target protein so that an active kinase is brought into proximity
to the target protein to initiate phosphorylation.
1

Public health relevance
PROJECT NARRATIVE We propose to develop a new class of heterobifunctional small molecules that can induce phosphorylation of any given protein-of-interest on demand by using kinase inhibitors. PHS 398/2590 (Rev. 06/09) 1 Continuation Format Page